PS03, a bifunctional RNA therapeutic to induce exhaustion in diabetogenic T cells

T cell exhaustion is an important mechanism that controls the clinical manifestation of Type 1 (T1) diabetes
in mice and humans. In humans, T cell exhaustion correlates with the length of the honeymoon phase; islets
persistent in patients with a long T1D history express PDL1; and autoantibodies positive, non-diabetic patients
undergoing anti-cancer treatment with PD1 inhibitors develop fulminant diabetes. In preclinical settings, PDL1 is
upregulated on the β cells of NOD mice that do not develop T1D, anti-PD1 treatment induces T1D in male NOD,
and transgenic expression of PDL1 on β cells prevents T1D. These data suggest that modulation of PDL1 on β
cells is an important yet unexplored therapeutic opportunity to prevent diabetes clinical manifestations.
We propose using a new bifunctional RNA therapeutic called PS03 to modulate PDL1 specifically on β cells.
PS03 comprises the β cell-specific aptamers we have recently isolated (as targeting agents) covalently linked to
a small activating RNA (saRNA) to upregulate PDL1.
We hypothesize that PS03 will block diabetogenic T cell function, induce their exhaustion, and halt the
autoimmune attack in T1D. We also hypothesize that PS03 will leave T1D-unrelated T cells untouched while
other PD1 agonists may affect them.
Our preliminary data shows that PS03, given systemically to NOD mice, PS03 upregulated PDL1 in β cells
without modulating this gene in α and acinar cells nor on all other tissues evaluated. A treatment course with
PS03 increased the number of pancreatic CD4+ and CD8+ T cells with an exhausted phenotype in NOD mice. A
short treatment course, started one week before onset with a former unoptimized PS03 formulation, prevented
T1D in 40% of the mice for over a year.
Building on these promising results, we propose to compare PS03 with the soluble PD1 agonist fc-PDL1 by:
1) determining the effects of PS03-mediated PDL1 upregulation and fc-PDL1 on TCR signaling of diabetogenic
and islet infiltrating T cells; 2) characterizing the effect of PS03 and fc-PDL1 treatments on diabetogenic and
T1D unrelated T cells, on the immunological landscape, and β cell function; and 3) determining the effect of the
two drugs on T1D progression. We will use state-of-the-art techniques such as pancreatic living slices, multiplex
quantitative immunofluorescence microscopy, scRNA seq, and spectral flow cytometry to unveil the effect of
PS03-induced, β cell-specific PDL1 upregulation on the immune system and insulin-producing cells.
PS03 exists in both mouse and human versions; it is produced at GMP grade with an oligo synthesizer without
contaminations and with a fluorinated backbone that makes it RNAse resistant and invisible to the immune
system. To our knowledge, this is the only non-viral reagent that can modulate PDL1 expression selectively on
murine and human β cells in vivo, allowing us to understand the mechanisms that regulate T cell exhaustion in
the islets and, hopefully in the future, provide new therapeutic options to patients recently diagnosed with T1D.

Public health relevance
Project Narrative While the discovery of proteins called immune checkpoints has revolutionized the clinical treatment of cancer by promoting tumor immune rejection, the reverse process (i.e., the induction of immune checkpoints in β cells) to restrain autoimmunity has not yet been explored in Type 1 diabetes. We have developed PS03, a bifunctional drug that, once administered, recognizes insulin-producing cells and instructs them to express an immune checkpoint called PDL1. PS03 allows insulin-producing cells to defend themselves from autoimmunity and potentially prevent or reverse Type 1 diabetes. As the first step in developing a new treatment for autoimmune diabetes, we will test the efficacy and safety of this new smart drug in comparison with other untargeted drugs in preclinical models.